STRUCTURE/FUNCTION RELATIONSHIPS IN FERRITIN PROTEINS

DESCRIPTION: This proposal has three specific aims. The first two are the same in intent but refer two different Ftn, a mammalian Ftn, horse spleen ferritin (HoSF) and a bacterial one, from Azobacter vinelandii (AVBF). This aim is to use microcoulometric methods to quantitatively link the flux of H(+) and e(-) to the amount of iron deposition and release from Ftn. Individual H and L chaims and site-directed mutant proteins will be used to localize the protein domains and residues associated with Fe binding and ferroxidase activity. Mossbauer spectroscopy will be used to quantitate the redox distribution of Fe that is incorporated into the Ftn. The third aim is to determine the relationship between phosphate in the Ftn core, the deposition of Fe in the core and the reactivity of the Fe in the core and to determine whether the modulation of these properties by phosphate is unique to this anion.